AIDS IN PREGNANT WOMEN, NEWBORNS AND INFANTS--STUDY OF VERTICAL TRANSMISSION

A study to expand current knowledge with regard to the transmission of huma retroviruses (HTLV I, II, and III) from pregnant women to their offspring and the consequent development of clinical and subclinical abnormalities.